Regulation of DNA synthesis in response to DNA damage

PROJECT SUMMARY
Genomic DNA is constantly challenged by DNA damage either spontaneously induced during cellular
metabolism or generated by exogenous DNA damaging agents. During DNA replication, DNA lesions can
cause the stalling or collapse of replication forks. Fork collapse results in the formation of DNA double-strand
breaks (DSBs). MCM8 and MCM9 (MCM8-9) form a helicase complex that promotes the repair of DSBs by
homologous recombination. We recently identified MCM8IP as a novel interactor of MCM8-9 that maintains
genomic integrity after replication stress. In particular, we showed that MCM8IP promotes DSB repair by
homologous recombination, facilitates the restart of replication forks arrested by DNA lesions and protects cells
from DNA damage generated by replication stress-inducing agents. Despite these important preliminary
findings, the precise mechanisms of action exhibited by MCM8IP, MCM8 and MCM9 during DNA
recombination and replication remain to be elucidated. MCM8 or MCM9 have been reported to act as tumor
suppressors and recent cancer genomic analyses have evidenced mutations in MCM8, MCM9 and MCM8IP in
multiple cancer types. The goals of this proposal are to define the precise biochemical and cellular activities
displayed by the MCM8IP-MCM8-9 complex for suppressing genomic instability and to examine how these
activities are affected by mutations in MCM8IP, MCM8 and MCM9 identified in tumors. In particular, we
propose 1) to define the biochemical activities and physical interactions exhibited by the MCM8IP-MCM8-9
complex for preserving genomic integrity; 2) to elucidate the mechanisms by which MCM8IP-MCM8-9
promotes DSB repair and ensures replication fork progression in response to DNA damage; 3) to evaluate the
contribution of MCM8IP, MCM8 and MCM9 cancer-associated mutations to genomic instability. Our approach
will utilize innovative proteomic methods, state-of-the-art genome editing technologies, single-molecule
analyses of replication dynamics, electron microscopy and super-resolution imaging. We anticipate that our
studies will define the unique mechanisms employed by the MCM8IP-MCM8-9 complex to suppress genomic
instability and will provide insights into the potential contribution of MCM8IP, MCM8 and MCM9 cancer-
associated mutations to cancer etiology.

Public health relevance
PROJECT NARRATIVE Defective repair of DNA lesions causes the accumulation of mutations and genomic rearrangements that predispose to cancer development. MCM8 and MCM9 are tumor suppressor genes that promote DNA repair. Understanding the impact of MCM8 and MCM9 cancer-associated mutations on genomic instability will provide novel and important insights into the molecular events that drive tumorigenesis.